Develop combinatorial non-viral and viral CRISPR delivery for lung diseases

Project Summary
The ability to correct disease gene mutations in vivo has broad potential utility for both therapy
and basic research. CRISPR/Cas9 is a powerful RNA-guided tool for genome editing. Our
recent discovery that CRISPR/Cas9 delivery can cure genetic disease in adult mouse liver
provided proof-of-concept of gene correction therapy in vivo. The main goal of this proposal is to
establish innovative delivery technologies to maximize the efficiency of CRISPR delivery and
gene correction in disease-relevant lung cell types. The impact of this project is a novel
paradigm of lung-targeted delivery tools for CRISPR-mediated gene correction. The
development of safe and effective delivery vehicles and genome editing tools will guide future
studies for CRISPR-mediated gene therapy. This project has three aims that focus on different
aspects of lung-directed somatic genome editing: Aim 1: Optimize NP+AAV combination for
delivery and gene correction in mouse lung; Aim 2: Identify the best AAV capsid for lung
delivery and optimize AAV genome as donor template for HDR; Aim 3: Characterize NP+AAV
developed in the UG3 phase in macaque models. This project will develop innovative designs of
adeno-associated virus and nanoparticles to significantly improve the efficiency, cell specificity,
and safety of CRISPR delivery in vivo.

Public health relevance
Project Narrative Efficacy and safety limitations in current gene editing technologies have hindered efforts to treat genetic lung diseases. This proposal seeks to develop and validate a combinatorial delivery approach that uses non-viral and viral vehicles to efficiently transport gene editing tools to disease-relevant cells in the lung. Completion of our work will establish safe and effective delivery vehicles that will guide the design of future gene therapies for genetic disorders.